Improving HIV Prevention Services among Socioeconomically Disadvantaged Cis-gender Women

Eliminating perinatal HIV in the U.S. is within reach. The overall rate of perinatal HIV infections in
2020 was 1:100,000, but there were disparities by race and ethnicity. For example, the rate of
infections among Black/African American infants was 3.8:100,000, which is four and nearly 13 times
the rates among Hispanic/Latino and White persons, respectively. To reduce the number of babies
born with HIV, we must ensure pregnant women and their partners have access to HIV testing and
PrEP. Opt-out HIV testing of the pregnant person is an effective evidenced-based strategy to prevent
perinatal HIV transmission; however, this approach does not identify or address those at risk of HIV
seroconversion during pregnancy. Ending the HIV epidemic may not be successfully achieved inn
certain populations without the intentional engagement of the male partner during the pregnancy
period. Male partner engagement benefits a wide range of outcomes related to maternal, child, and
family wellbeing. U.S. guidelines recommend that partners of pregnant women undergo HIV testing
when their status is unknown. However, this recommendation has not been implemented due to a
lack of successful implementation research. Whereas the parent hybrid effectiveness-implementation
trial (R01MH132146) addresses barriers to HIV testing and PrEP uptake among a non-pregnant
population, this administrative supplement focuses on socioeconomically disadvantaged pregnant
persons and their male partners. We aim to conduct a pilot mixed methods study to engage male
partners in HIV prevention services during prenatal care. We hypothesize that the uptake of HIV
prevention services (i.e., counseling, HIV testing, and PrEP) will increase with the engagement of the
male partner (in-person or virtually) and the assessment of their HIV risk. This project will assess the
perceived risk of HIV infection among the pregnant person and their male sexual partner with a
validated survey. Next, we will offer male partners home-based HIV testing. Last, we will identify
facilitators and barriers to testing uptake using in-depth interviews.

Public health relevance
This research focuses on evidence-based strategies to reduce perinatal HIV transmission in the United States. This includes assessing the perceived risk of HIV infection with a validated survey, determining the proportion of male partners who accept and complete home-based HIV testing, and conducting in-depth interviews to obtain feedback. Doing so can reduce the number of babies born with HIV and ensure better health for mothers and their families.